Evaluating Smoking Cessation and Harm Reduction Approaches among People Living with HIV/AIDS in South Africa

ABSTRACT
South Africa has the greatest burden of HIV/AIDS worldwide (19.5% adult prevalence) with approximately 8.2
million people living with HIV/AIDS (PLWHA) in 2021. Combustible cigarettes (CC) has profound health
implications among PLWHA. CC smoking in PLWHA puts them at increased risk for a host of serious HIV-
related co-morbidities and premature death compared to nonsmoking PLWHA. There is an urgent need for
novel feasible and efficacious strategies for CC cessation and harm reduction addressing these challenges
among PLWHA in general, and in South Africa in particular. This proposal aims to address the unmet need for
feasible and efficacious strategies for reducing CC use among PLWHA in South Africa, which has the potential
to significantly improve the health and long-term survival of PLWHA CC smokers. The proposed intervention is
based on the Information-Motivation-Behavioral Skills (IMB) model, and informed by our ongoing research. Using a
simultaneous embedded mixed methods approach, we will evaluate a telehealth program targeting CC harm
reduction, comparing E-cigarettes (EC) to nicotine replacement therapy (NRT) that is enhanced by integrating
ecological momentary intervention (EMI) texting. As such, this proposal will significantly build research capacity
in South Africa to conduct telehealth tobacco treatment interventions using innovative EMI approaches
enhancing participants’ engagement, as well as state-of-the art evaluation approaches.
The Specific Aims are to: 1) Adapt an existing telehealth intervention for CC harm reduction to the South
African context, and 2) Determine the feasibility and acceptability of adapted intervention (primary outcomes),
and Estimate and Compare the preliminary effects of EC and NRT on CC reduction (secondary outcomes)
using a pilot randomized controlled trial (RCT) design. We will adapt an existing CC harm reduction protocol.
Recruiting PLWHA smokers from eight healthcare facilities in the Western Cape in South Africa providing ART
to PLWHA, we will refine and finalize the intervention to be evaluated in a pilot RCT 3-group design (N=90).
Arm 1 (Control): Referral to quit-line; Arm 2: Telephone counseling + EMI + combination NRT (patch +
lozenge); Arm 3: Telephone counseling + EMI + EC. Consistent with a pilot RCT, primary outcomes will be: A)
Feasibility of the intervention as defined by Recruitment, completion, and follow-up rates, and B) Acceptability
as assessed by the Client Satisfaction Questionnaire and interviews. Secondary outcomes include 1) IMB
theory-based mechanisms of change, 2) proportion of CC smokers achieving 7-day point prevalence
abstinence, verified by exhaled carbon monoxide (<6 ppm) at 3- and 6-months, 3) reductions in cigarettes per
day compared to baseline, and 4) changes in health outcomes. This proposal will build capacity and lay the
groundwork to help decrease CC smoking among PLWHA in South Africa.

Public health relevance
PROJECT NARRATIVE Smoking-related illnesses are leading causes of non HIV/AIDS-related deaths among people living with HIV/AIDS (PLWHA). To date, no intervention has adequately address smoking cessation among PLWHA, especially in South Africa. Building on our previous work and our expertise, in collaboration with our South African partners, we will adapt an evidence-based interactive telehealth harm reduction intervention to promote cigarette smoking abstinence among PLWHA, and conduct a pilot randomized controlled trial to examine feasibility, acceptability and potential efficacy of the intervention.